Auditory Cortex Connectivity in Emerging Psychosis

Summary Auditory verbal hallucinations (AVH) are a pervasive debilitating symptom of psychosis. Understanding the pathology and pathophysiology underlying AVH would provide scientific knowledge about brain abnormalities in psychosis, and reveal a target neurobiological system for novel interventions such as brain stimulation. Yet, it is not known where in the brain disorders of structure or function lead to AVH, what role gray matter (local information processing) and white matter (information flow between distributed gray matter areas) abnormalities play, whether distinct patterns of pathophysiology underlie different types of AVH, when neurobiological abnormalities emerge in the prepsychotic prodromal phase, and how pathology and pathophysiology progress in the early disease course after psychosis and AVH emerge. This project aims to understand the neurobiology of AVH by examining structure and function in a left-hemisphere dominant language circuit thought to be involved in the genesis of AVH cross-diagnostically during initial stages of psychosis comprising the clinical high risk stage, the first psychotic episode stage, and longitudinally into the early psychosis stage. Individuals will express a range of severity of auditory perceptual aberrations, beginning with no symptoms, progressing through attenuated psychotic auditory misperceptions and then AVH of increasing intensity and duration, culminating in severe constant AVH. Our overarching hypothesis is that AVH are caused by a final common pathway of overactivity in left Wernicke's area that leads to overstimulation of upstream auditory sensory cortices and downstream semantic language stores. We will examine neurophysiology (simultaneous EEG and MEG) and hemodynamic measures of brain activity (MRI-based arterial spin labeling) to assess resting level activation and network functional connectivity in a distributed frontal (Broca's area), temporal (Wernicke's area and primary auditory cortex), and limbic system (putamen) language-related circuit, gray matter volumes in these areas (structural MRI) and the integrity of the white matter tracts connecting them (MRI-based Diffusion Spectrum Imaging), and EEG & MEG during a verbal fluency task. Our pilot data indicate that worse AVH are associated with increased verbal fluency at all disease stages. Further AVH of voices commenting appear to arise due to hypo-connected Broca's and Wernicke's areas, whereas AVH of other (typically negative) voices are associated with hyper-connectivity with the limbic putamen. We hypothesize that abnormalities in this language system will be detected in the prodromal and at risk stage that will correlate with auditory perceptual aberrations, in the first episode stage that correlate with AVH intensity, and that the pathology and pathophysiology will worsen during the first year post-psychotic break, particularly in the white matter integrity and the network functional connectivity dynamics. Regarding therapeutic targets, if Wernicke's overactivity is shown to be the final common pathway for AVH, then a rationale for inhibitory brain stimulation is provided, and if different components of the language circuit are implicated in the phenomenology of AVH, then strategies to differentially target cortical and subcortical structures are warranted.

Public health relevance
Narrative Auditory verbal hallucinations are a debilitating and distressing symptom in psychosis that likely arise from abnormal activation with a left hemisphere dominant language circuit. Understanding where structural deficits occur and how pathophysiology in the distributed circuit gives rise to auditory hallucinations, and how such pathology and pathophysiology arise during the pre-psychotic and early stages of psychosis would be a major advance. Such knowledge would be a crucial first step in development of targeted noninvasive brain stimulation techniques during early disease course to prevent the life long disability associated with a psychotic disorder.